Medical Scientist Training Program

This proposal requests support for the MSTP at the University of Cincinnati College of Medicine (UCCOM). Our dual-degree program was established in 1985 and has been continuously NIH-funded for over 20 years. It enrolls 9 new students each year and currently includes 73 students. A unique and central feature of our program is that our MSTP is a partnership between a top ranked college of medicine and a premier children's hospital (Cincinnati Children's Hospital). The atmosphere afforded by seamless alignment of research and clinical practice provides the ideal research environment for significant and impactful health related research. The overarching mission of the UCCOM MSTP is to recruit, mentor, and educate a diverse group of physician scientists who will become leaders in their chosen careers that integrate clinical medicine and research to advance clinically relevant science and improve health throughout the world.
Our Program is supported by a solid infrastructure in clinical and research training. Our students can choose from 11 diverse graduate programs. The success of our Program is best illustrated by the success of our graduates. Our students come from a diverse applicant pool drawn from across the nation. For the class that matriculated in the Fall of 2021. we had 189 applicants, which included applications from 37 states, Washington DC, and Puerto Rico. Our current MSTP students include 12% URM. The average time to complete our MSTP for the last 10 years is 8.0 years and our students have matched at the most competitive residency programs.
Since the last funding period, several important and exciting developments have taken place, which include increases in the size and quality of our applicant pool including URM and disabled/disadvantaged applicants, our program faculty, extramural research support among our program faculty, number and breadth of training opportunities for MD/PhD candidates, increased individualized advising, expanded multi-pronged mentoring approaches, implementation of significant DEi initiatives including efforts designed to increase recruitment and retention of URI/M, disabled and disadvantaged students, expansion of both UCCOM and CCHMC facilities, and implementation of evidence based approaches to mentoring including required mentor training for all participating faculty. We are confident that we can continue to achieve our aims and meet the central goal of our program. Towards this goal, we are requesting support for 18 positions.

Public health relevance
The need for investigators who are well trained in both basic science and clinical research has been and continues to be an unmet need. NIGMS Medical Scientist Training Programs (MSTP) were developed to meet the need for more physician scientists and offer unique training opportunities. The UCCOM MSTP meets these goals and prepares graduates for diverse careers as physician scientists.